Quantitative Analysis of Cancer-associated EVs

Abstract
All cells in the body, including tumor cells, release small vesicles that can be found in blood,
cerebrospinal fluid, and even urine. Because each vesicle was released by a specific cell, their
analysis can tell us about the cells from which they came, including whether that cell was
infected, cancerous, or malfunctioning in some way. We will develop assays and kits to enable
cancer researchers to analyze these vesicles to improve the ability to understand, detect and
treat cancer.

Public health relevance
Narrative To meet the needs of cancer researchers investigating the role of extracellular vesicles in cancer we will develop and validate assay kits that enable the high-resolution measurement of EV number, size, and surface cargo. These assays will enable researchers to study the roles of EVs in the pathology and response to cancer. Such studies may lead to the development of new biomarkers to assess cancer type and target and monitor treatment.